Dopaminergic modulation of prefrontal cortex during working memory

PROJECT SUMMARY ABSTRACT
Dopamine (DA) is an critical modulator of brain activity. Disruption of DA signaling in the prefrontal cortex (PFC)
has been proposed to underlie cognitive deficits in major mental disorders including schizophrenia and attention-
deficit hyperactivity disorder (ADHD). Working memory (WM) is an important cognitive process for temporarily
holding and manipulating goal-directed information, that depends on DA in the PFC. Yet despite decades of
investigation, the key circuit mechanisms underlying dopaminergic modulation of PFC cells during WM remain
poorly understood. This gap in knowledge has in turn limited our ability to gain better insights into the
pathophysiology of such mental disorders.
The overall goal of this study is to use multiple complementary state-of-the-art techniques to
investigate DA signaling in PFC during a well-established parametric WM task. Technical limitations have
hindered our ability to reliably measure rapidly-evolving DA signals in the PFC. This is now changing. I will use
retrograde viral infection tools to optogenetically distinguish PFC-projecting from striatal-projecting DA cells in
VTA. I will test the hypothesis that PFC-projecting DA cells encode a cue saliency signal, gating information flow
to PFC. Using a novel optical DA sensor, I will characterize the DA dynamics in subregions of medial PFC and
test the hypothesis that DA transiently increases during the delay-period, and that the magnitude of this increase
is linked to WM performance. Finally, using head-mounted microendoscopes I will optogenetically manipulate
PFC DA release while simultaneously monitoring distinct subpopulations of PFC neurons. If successful, this
project will provide a novel window onto dopaminergic modulation of PFC during cognitive processes.
My long-term career goal is to investigate the circuits mechanisms of cognitive control in the brain with a
specific interest in how impairment in these circuits contributes to major psychiatric disorders. I have a strong
computational and signal processing background. I have received rigorous training in behavioral neuroscience,
optogenetics, neurophysiology, and fiber photometry. Yet, I need additional technical and conceptual training
critical to my mission. My mentor and co-mentor are ideally situated to provide critical guidance to this project
and to my career development. The UCSF environment provides numerous training opportunities with an
emphasis on preparing the next generation of leaders in biomedical research. These include speaking
opportunities at various internal programs, scientific leadership and management workshops courses, grant
writing courses and internal review panels, and mentoring opportunities specific to postdoctoral scholars seeking
independence. I plan to take advantage of all the opportunities provided through this mentored career
development award to establish myself as a highly effective neuroscientist and independent investigator.

Public health relevance
PROJECT NARRATIVE Disruption in dopamine (DA) signaling in the prefrontal cortex (PFC) is a key hallmark of the cognitive symptoms of a number of major mental disorders including schizophrenia and attention-deficit hyperactivity disorder (ADHD). Yet despite many years of investigation, the DA signals in PFC, and how exactly they affect cognitive processes, remain poorly understood. In this project, I will use multiple complementary state-of-the- art technologies to study DA dynamics in PFC during a cognitively-demanding task to reveal the circuit mechanisms underlying such cognitive deficits.